Clinical Trial Readiness to Solve Barriers to Drug Development in FSHD

The overall aim of this study is to hasten drug development for facioscapulohumeral muscular dystrophy
(FSHD). Recent breakthroughs in FSHD research have identified the primary disease mechanism as the
aberrant expression of a normally silenced gene, DUX4, resulting in a toxic gain-of-function. This disease
mechanism is particularly amenable to knock-down of DUX4 using epigenetic strategies or RNA therapies, as
well as to other interventions targeting the downstream effects of DUX4 expression. There are many drug
companies actively working towards disease-targeted therapies, and two clinical trials either under way now, or
planned to start in early Fall 2016. However, meetings with industry, advocacy groups, and FSHD researchers
have identified several gaps in our clinical trial arsenal, and clinical trial planning as a major goal for the
community. Consequently, there is an urgent need to establish the tools necessary for the conduct of currently
planned and expected therapeutic trials in FSHD. To this end we propose to develop two novel clinical
outcome assessments (COA), a composite functional outcome measure (FSH-COM) and skeletal muscle
biomarker, electrical impedance myography (EIM). In addition there is broad consensus a better understanding
of the relationship of genetic and demographic features to disease progression will be necessary for
enumerating eligibility criteria. The specific aims are to: 1. Determine the multi-site validity of the COAs, 2.
Compare the responsiveness of new COAs to other FSHD outcomes and determine the minimal clinically
meaningful changes, and 3. establish FSHD cohort characteristics useful for determining clinical trial eligibility
criteria. To achieve these aims, a multicenter, prospective, 18 months study of 150 subjects is proposed.
FSHD is the second most common form of adult muscular dystrophy with an estimated prevalence of 1:15,000,
and there are currently no effective treatments. Hastening drug development will have significant impact on
approximately 21,000 affected individuals in the United States. Other than manual muscle testing and
quantitative myometry, there are no validated outcome measures used consistently in clinical trials in FSHD.
This proposal will develop novel outcome measures for use in both early phase studies (EIM) and in late phase
registration studies (FSH-COM), and will determine genetic or demographic predictors of progression important
for defining key eligibility criteria. The process of FDA qualification for both COAs has already been initiated.
An established FSHD clinical trial research network, supported by the major FSHD advocacy group, with
experienced clinicians and clinical evaluators will be utilized to conduct the study. Data and statistical support
will leverage existing clinical trial infrastructure through the Muscle Study Group. It is expected that the study
will validate both COAs for use in future FSHD clinical trials. Moreover, the study will provide FSHD cohort
characteristics that will be valuable for establishing eligibility criteria for future clinical trials. The data from this
study will be made available for any investigator or company pursuing treatments for patients with FSHD.

Public health relevance
Narrative: The primary cause of facioscapulohumeral muscular dystrophy (FSHD), a common adult-onset dystrophy, was recently discovered identifying targets for therapy. As multiple drug companies pursue treatments for FSHD, there is an urgent need to define the clinical trial strategies which will hasten drug development, including creating disease-relevant outcome measures and optimizing inclusion criteria. This proposal will develop two new outcome measures and optimize eligibility criteria by testing 150 patients in 7 sites over a period of 18 months.